Post-Vent, the Sequelae: Personalized Prognostic Modeling for Consequences of Neonatal Intermittent Hypoxemia in Preterm Infants at Pre-School Age

Project Summary / Abstract
This is the application from collaborators of the Prematurity-Related Ventilatory Control (Pre-Vent): Role in
Respiratory Outcomes NHLBI Collaborative Program. Central to this proposal is a prospective study entitled
“Post-Vent, the Sequelae: Personalized Prognostic Modeling for Consequences of Neonatal Intermittent
Hypoxemia in Preterm Infants at Pre-school Age”. This multicenter proposal innovatively combines detailed
clinical phenotyping with advanced analytics of longitudinal recordings of intermittent hypoxemia (IH) events to
develop personalized prognostic models of long-term outcomes that could transform clinical care by allowing for
timely identification of at-risk infants and specific pathologic IH patterns for future trials of targeted intervention.
Extremely premature birth and various postnatal factors can negatively affect outcome. In a significant proportion
of extremely premature infants the sequelae persist beyond infancy with relatively high rates of asthma and sleep
disordered breathing (SDB) in childhood and worrisome prevalence of neurodevelopmental impairment (NDI).
This multicenter proposal will systematically and innovatively examine the interaction between IH during neonatal
intensive care and these sequelae by means of detailed clinical phenotyping and advanced analytics. The
proposed investigation will provide personalized prognosis and identification of infants at risk of poor long-term
outcome that could transform clinical care and uncover targets for preventive or therapeutic strategies.
The main goal of this proposal is to build prognostic models of asthma, SDB, and NDI at pre-school age in former
extremely premature infants based on physiologic waveforms and clinical characteristics in the neonatal
intensive care unit. To achieve this goal this time-sensitive proposal leverages the population, research structure
and expertise, and analytic resources developed for the NHLBI-funded Pre-Vent collaboration.

Public health relevance
Project Narrative Survival of infants born extremely prematurely has improved, but these babies go on to experience high rates of childhood health problems including asthma, breathing abnormalities during sleep, and poor developmental outcomes. Currently, the mechanisms causing such outcomes remain unclear, impairing the ability of the clinician to identify both at-risk infants and targets for intervention. This study will utilize advanced analytics platforms paired with detailed health outcomes through pre-school age in a cohort of prematurely born children to further our understanding of the pathways leading to abnormal outcomes in these children, empowering early identification and targeted treatment to improve health outcomes.